Defining a role and functional consequences of the disordered N-terminal domain from the Borna Disease Virus Phosphoprotein

Project Summary: Defining a role and functional consequences of the disordered N-terminal domain from the
Borna Disease Virus Phosphoprotein
PI: Madison A. Stringer
Borna Disease Virus causes fatal neurological diseases in mammals. Among a handful of proteins in the viral
genome, phosphoprotein (P) is an essential component for genome replication. It required for bridging the
genome to the polymerase, and this bridging requires an oligomeric form of P. P itself has three domains: the
central helical domain is flanked by two intrinsically disordered regions (IDRs). The helical domain binds the
polymerase, the C-terminal IDR is required to bind the nucleocapsid protein, and the N-terminal IDR is required
for binding RNA and driving the formation of compartmentalized viral factories in the cell. Despite its essential
role in genome replication, we know very little about P, and all biochemical studies to date have focused on the
folded domain. I hypothesize that the physical properties encoded in the sequence of the IDRs are important to
P’s functions. A major knowledge gap is understanding how the N-terminal IDR (NTD) specifically can
modulate the functions of P: its self-association, RNA binding, and how oligomerization and RNA binding
properties of P can influence the activity and localization of the viral polymerase. My central hypothesis is
that the prolines and charged residues in P’s sequence modulate the activities of P by enhancing its
self-association and affinity to RNA, ultimately altering L localization and activity in cells. To test this
hypothesis, I will use a combination of biochemical and biophysical techniques to characterize the NTD and its
interactions. Overall, this proposal aims to biophysically characterize P and use insights from these
experiments to allow for mechanistic understanding of its function in cells. At the same time, it will offer a
fundamental opportunity to develop skills in single-molecule spectroscopy, cell biology, and virology, fostering
the multidisciplinary training needed for my future as an academic biomedical investigator.

Public health relevance
Project Narrative Viruses in the Mononegavirales order can cause extremely severe infections with high risk to human health. In order to develop effective antiviral treatment options, more must be known about the molecular mechanisms of the proteins that coordinate viral replication. This proposal aims to study the biophysics of viral proteins and translate those findings into cells in order to provide new avenues for development or targeted viral inhibitors.